Enzyme-Inspired Multimetallic Cooperativity: Leveraging Metal Pairing Effects for Heightened Reactivity

Project Summary
Polynuclear mixed-metal active sites enact multielectron transformations central to global ecology. For example,
dinitrogen reduction, which is critical for enabling all of life’s biological processes, occurs at an iron-molybdenum
cofactor that proves markedly more efficient than its iron-vanadium homolog. Likewise, the oxygen evolving
complex of photosystem II features a Ca2+ ion and only maintains oxygen evolution function with Ca and Sr. This
specificity is in stark contrast to numerous enzymes that maintain utility when their native metals are substituted
for interlopers. These observations raise a critical research question: Why do enzymes select specific metals for
specific functions? with the corollary: Why are certain enzymes promiscuous in terms of active site composition?
Synthetic model chemistry is perfectly suited to address these queries, as metal substitution in the active site is
most often decoupled from perturbations of the protein secondary and tertiary structure that are impossible to
emulate abiologically. Using our group’s expertise in preparing multimetallic constructs, the goal of this proposal
is to address key questions related to (i) how metal ion identity alters electronic structure in multimetallic active
sites, (ii) how well-defined Lewis acid adducts can tune redox potential, pKa, and therefore BDFEs in bimetallic
bis(µ-hydroxo) diamond cores, (iii) what is the role of interstitial elements (e.g. O, S, N, P) in tuning the
physicochemical properties of multimetallic clusters, and (iv) how proximal metal sites can both cooperatively
bind substrates and template stabilizing hydrogen bonds? The viability of these model systems will be
established by both spectroscopic comparison to, and reactivity recapitulation of, enzymes of interest (including
homobimetallic oxidases, mixed-metal oxidases, and nitric oxide reductase). The systematic connections
between model complex structure and function will provide a contextual framework for the development of novel
modes of enzyme-inspired reactivity. Exploring oxidant activation proclivity and C–H bond functionalization ability
in these systems, sets the stage for the discovery and optimization of new methods in pharmaceutical
development, where the requisite reactivity demands the cooperative multipoint binding, efficient redox
distribution, and reactive intermediate stabilization that multimetallic architectures can uniquely provide.

Public health relevance
Project Narrative The proposed research targets the synthesis and characterization of multimetallic architectures designed to inform complex enzyme active-sites capable of life-essential multielectron processes. Key mechanistic questions pertaining to the effects of metal ion identity and modulating electronic communication between metals will be tested to inform structure/function relationships in metallocofactors relevant to human health. Ultimately, the outcomes of this work provide a framework for new catalyst development for preparation of therapeutic agents and biochemical probes.